Genetic code expansion for the construction of beyond rule-of-5 compliant macrocyclic peptide libraries

Modified Project Summary/Abstract Section
Many intracellular targets involve intracellular protein-protein interactions that are “undruggable” because the binding surfaces are too large and featureless to be blocked by a standard rule-of-5 compliant small molecule. Recently, there have been attempts to catalog molecules that are orally bioavailable but lie beyond the rule of five (bRo5) to access these targets. Macrocyclic peptides can inhabit this bRo5 space, and a key advantage to using peptides as bRo5 molecules is that there are many mature techniques for finding peptide binders from vast libraries. Arguably, the most powerful of these techniques is mRNA display, which allows creation of peptide libraries containing over 10 trillion variants, 6-7 orders of magnitude larger than a standard peptide library prepared on beads. The extreme diversity of these libraries has enabled many successes in inhibitor development. Yet these successes are disconnected from real drug discovery, because the peptides uncovered are much too large to be bRo5 compliant. Libraries that are short in sequence and bRo5 compliant can be created by mRNA display, but these libraries lack the diversity needed to uncover potent inhibitors because standard mRNA display is limited by the genetic code to ~20 variants at each position. In this proposal, strategies to enhance this positional diversity will be pursued. This will first involve breaking the degeneracy of the standard genetic code through isolation of fully modified tRNA isoacceptors. Based on codon reading rules it is predicted that this will allow the addition of 10 non-canonical amino acids (ncAAs) to the code. The second aim focuses on combining these newly defined codon reading rules and previously described tRNAs with unnatural base pairs to allow expansion of the genetic code to the use of 40 monomers at each position. This aim will also focus on developing and testing a curated group of aminoacyl-tRNAs for the future creation of bRo5 compliant libraries containing billions of variants for use in drug discovery.

Public health relevance
Modified Public Health Relevance Section PROJECT NARRATIVE. The proposed research aims to build the first stages new technology with the potential to dramatically enhance the discovery of drugs that bind to and block interacting proteins associated with disease. The technology involves expanding the genetic code to enable the creation of large collections of molecules from which potential drugs can be found.